Training in the Neurobiology of Aging and Alzheimer's Disease

Summary
With the “graying of America” we are faced with the need to address the ever increasing number
of individuals in our society who have age-associated nervous system diseases and conditions.
To address this problem, we need multidisciplinary approaches to facilitate the discovery of the
mechanisms, treatments and prevention of these diseases. Active, integrated research-based
training of pre-doctoral students is a key to re-supplying the research personnel needed to
address these biomedical health care issues in a sustainable manner. Herein we propose to
continue a successful pre-doctoral program at the University of North Texas Health Science
Center (UNTHSC) that focuses on the neurobiology of aging. During this funding cycle we
supported 33 fellows, of whom 22 completed their training and their Ph.D. The trainees were
very productive and published 46 peer-reviewed papers to date; we also trained 7 (of 33 =
21.2%) minority students. Importantly, we increased our retention/graduation rate from 84.6% in
the prior 5-year funding period to 100% in the most recent funding cycle. The proposed training
program will enhance an already strong and successful training program in the neurobiology of
aging. The continuation of our predoctoral training program is proposed, as our Institute for
Healthy Aging has matured through the addition of faculty and continued funding of program
project grants, such as that led by the PI, Dr. Meharvan Singh. Such growth has facilitated more
basic, translational and clinical research into the causes, treatment and prevention of brain
aging and Alzheimer's Disease at the UNTHSC. Collectively, these new initiatives create a
stimulating environment for the training of predoctoral students in the neurobiology of aging.
Unique and innovative features of the training program for the next period of funding include: (1)
Several experiential learning opportunities to include the Geriatrics Skills Lab and the
Translational Aging & Alzheimer's Disease Research Program; (2) our continued emphasis on
diversity training, that resulted in greater than 20% minority participation in the training program;
3) Career counseling and interview skill development program, 4) techniques in neuroscience
program; 5) our institutional support which will expand those students who will have access to
some or all of this training program; 6) our focus on the development of research excellence and
leadership among our trainees; and 7) our Mentoring-the-Mentor Program which trains junior
faculty in mentoring trainees under the guidance of a senior faculty. Collectively, these attributes
of our Neurobiology of Aging Training Program has produced an outstanding program of training
that we wish to continue.

Public health relevance
Narrative Training in the neurobiology of aging is proposed to address the ever increasing number of individuals in our society who have age-associated nervous system diseases and conditions. We propose to continue a successful predoctoral training program that focuses on diversity training, scientific excellence and leadership, and preparation of trainees for successful careers in the neurobiology of aging, through intensive research and research-related activities and publication of high quality research reports. A substantial institutional commitment to support this training program has been made to help ensure continued success of this program.